Virginia Department of Agriculture and Consumer Services Rapid Response Team and

Rpi RsoseTam r jctSummry/Prooal Astrct TeVirgii Dprtmnt ofAgricltur nd CnsumrSrvics(VDACS) isseking fnigt sportteDprtmnt'sRpi Rsos Tam(RRT)adMnfacture odRegltory PrgrmStnars(MRPS)Imlmnttinan CntiutinPrjct. Th VAS odSafety...ScrityProgram metsall reqirmntstob ligil for tis fnig. Teproramservss testt’s mnufctrd fodreglatryprogramadhsa crrntFDA fodsafetyisectincntrct. I 09teFo Safty &SecrityProgramws wre fnin ner PA-9-8 (odPrtctinRpi Rsos TamadProrm Infrstrctur PrtotyePrjct). udig rcivdudr tis rviuscoerativ gremntwsutilizdt crat a fnctinl n itegratdRRTwiti Virgii icldigrpresnttin fromVAS ,teVirgii DprtmetofHalt,th DivisinofCnsliate aoratorySrvics, th DABltimor Disric Ofice andtheU.S Deparmen o Agriculure Allo hselaisgtdenaciove articiatei weklycllswer ac prviesa pateo nyoon-igoremergigisses imacting fo safetyad/rscritywithi Virgii.Isses brugtu n tecllsar iscssdbyallprticiatsada curseof futr ctinisagreduo yte grup. Tese cllsadteoter cmmnictinprcdres dvlpdudrteprvius fning surce av nbldVirgii to sigificntlyicrasetesedadefficincywit wic fobore utraksadoteremerecisar etctd,invstigtdadultimtlyrslvd. Aditinlly, fnig from teprviuscoerativ gremntwsutilize tocnucta etildslfassssmntoforagncy'sMnfactrdFo Regltory Prgrmadto evlpa imrvmntplntobring sclser t fll comlinc wit lltnstnarswiti teMRPS.Fnigprovie ytenwRAwillb tilizdt cntiuetedvlpmen o teRRTcncpt yimlmntingprcdurs gerd twrsitegratig te fo safty rsos yallproramsoeratigwit teCmmnwalt icldiglcl,stat,ad fderl arters.Aditinlly, fudswillb tilizdt raftteStnar Opratin Prcdursfr ctivitisoccrrin i testat icldig tedvlpmnt ofa statwiefodemergncy rsos ln. Wewillals cntiuewrko te evlpmntad rviewofanRR Bst PrcticsMnal.Fially,ay fnin rcivdwillb sdt frter ur program'sgal of civig fllimlmnttinofalltnstnarswiti teMRPS.

Public health relevance
Food Protection Rapid Response Team and Program Infrastructure Improvement Implementation Project (U18) Project Narrative Funding provided to support the Virginia Department of Agriculture and Consumer Services Rapid Response Team and Manufactured Food Regulatory Program Standards Implementation and Continuation Project will be utilized to enable Virginia to maintain a functional RRT and to further efforts started during the original funding period geared towards improving the speed and efficiency with which foodborne outbreaks and other such emergencies are detected and mitigated within the Commonwealth of Virginia. The new cooperative agreement will allow the Food Safety & Security Program to enhance procedures meant to improve coordination between food safety professionals at the local, state, and federal levels and continue work towards a completely integrated Virginia food safety system. Additionally, funding provided through the new RFA will allow the RRT to continue implementation of the Manufactured Food Regulatory Program Standards. Finally, continued funding will allow representatives from the Virginia RRT to continue to participate in other national initiatives including the development of a RRT Best Practices manual.